Geobiology of Cataracts

Cataracts are the leading cause of blindness worldwide. They can be caused by congenital mutations of
lens proteins or by various diseases including diabetes. We have recently studied mice carrying connexin
mutations (Cx46fs380 and Cx50D47A) that mimic human cataract-linked mutations. The lenses of these mice
accumulate calcium which forms precipitates that correspond to the cataracts. We hypothesize that bio-
mineralization is a general mechanism of cataract formation. We will characterize the composition of calcium
precipitates in connexin mutant mice and the relation between their formation and cataract development. We
will test whether mice with mutations of a different lens protein (γB-crystallin) or mice with experimentally-
induced cataracts also contain calcium precipitates. This proposal may give insights into fundamental
pathogenic mechanisms of cataracts and lead to new preventative/therapeutic approaches.

Public health relevance
Project Narrative: Cataracts are the major cause of blindness worldwide and of visual impairment in the United States. We have recently found that mutations of three different lens genes cause accumulation and precipitation of calcium in the lens corresponding to the cataracts in these animals. Studies are proposed to characterize these calcium precipitates and to determine the generality of calcium precipitation as a mechanism of cataract formation.